Leadership, Planning & Evaluation

LEADERSHIP, PLANNING, AND EVALUATION – PROJECT SUMMARY/ABSTRACT The University of Virginia Cancer Center (UVACC) is led by a Director and seven Associate Directors. These individuals work individually and together with each other and the Senior Leadership Group and the CCSG Executive Committee to advance the goals of the UVACC. These individuals and committees manage program planning and evaluation as a continuous and deliberate process. External guidance is provided by the External Advisory Board, which provides the UVACC with strategic and organizational advice, and the Community Advisory Council, which guides the UVACC to ensure a focus on improving cancer health across the catchment area. In parallel, the UVACC relies on internal monitoring and feedback to determine how to best implement these practices to advance its goals. This external-internal dynamic ensures a planning and evaluation process that generates Program changes; strengthens basic, translational, clinical, and population research leadership and infrastructure; provides new and improved Shared Resources; encourages collaborations; influences community outreach and engagement; guides training and mentorship activities; and implements recruitments.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.